Telehealth nursing intervention for children with complex health care needs

Project summary/abstract The overall objective of this study is to evaluate the effectiveness of a telehealth care coordination and case management nursing intervention for children with complex special health care needs. Children with complex special health care needs are those children who have multiple, complex, chronic health conditions who require health and related services of a type or amount beyond that required by children generally. When these children are hospitalized, they receive services as part of an integrated system that provides centralized record keeping and care orders, clearly identified roles and methods of communication for health professionals involved in their care, an established method to obtain equipment and supplies, and regular monitoring of the child's condition. However, when the same child is cared for at home, services are often fragmented, and rarely accessed and delivered in a coordinated system. The task of coordinating services and sharing information between providers almost always becomes the responsibility of the parent or guardian. Families report that their greatest challenges are the stress of coordinating multiple providers, and the disconnect and lack of communication between services and providers. This study will address these issues, using an advanced practice nurse program of telehealth care coordination and case management in support of these families. Either the telephone or telephone plus interactive video are used by an advanced practice nurse to provide care coordination and case management. Goals of the program are to (1) reduce the number of crisis or unplanned uses of health care services and increase the number of non-crisis or planned health care service usage, (2) improve the quality of life for these children and their families, and (3) reduce the deficit between help needed and help received for the families in caring for these children. The study objective will be accomplished using a three armed randomized controlled trial. Children will be randomized into a control group receiving usual care that includes LPN-delivered care coordination and RN-delivered telephone triage, an intervention group receiving APN-delivered telephone care coordination and case management, and another intervention group receiving APN-delivered telephone + video care coordination and case management services. It is hypothesized that as the level of telehealth use in coordination and management increases the utilization of unplanned, or crisis, health care service utilization will decrease, that families will receive more of their needed care, and quality of life for the children and their families will improve.

Public health relevance
Project narrative Two areas that are critical to the health and quality of life of children with complex special health care needs and their families are (1) care coordination and case management and (2) home telehealth. The lack of interdisciplinary research into the effectiveness of coordination and management interventions by advanced practice nurses represents a significant gap in the current knowledge of providing optimal care for children with complex special health care needs, while the lack of research into the efficacy of home-based telehealth in this population represents a significant gap in the current knowledge of pediatric telehealth. The randomized controlled trial described in this proposal will address both of these issues, with the goal of developing and testing advanced practice nurse based care coordination and case management programs with increased reliance on home telehealth technology to accomplish this objective.